Alzheimer's Disease Therapy via the MR Image-Guided Deletion of Microglial SHIP-1 with Focused Ultrasound

Microglia play a key role in Alzheimer’s disease (AD) pathogenesis and represent promising targets in
the development of new Alzheimer’s Disease treatments. INPP5D, a gene that encodes for the SH2-domain-
containing inositol phosphatase SHIP-1 and is predominantly expressed by microglia in the brain, has been
recently uncovered as a late-onset Alzheimer’s disease genetic risk factor. Furthermore, we have recently shown
that SHIP-1 deletion in brain-resident macrophages leads to greatly enhanced mobilization of microglia to
amyloid beta (A) plaques, augmented A phagocytosis, and improved neuronal health and cognitive function.
These results have led us to formulate the hypothesis that SHIP-1 is both a negative regulator of protective
microglial responses in A amyloidosis and a novel therapeutic target for ameliorating Alzheimer’s-related
disease. However, because global inhibition of SHIP-1 may cause multi-organ inflammation, its inhibition must
entail selective brain/microglial targeting. To achieve this selective targeting, in this proposal, we will develop
and deploy MR image-guided focused ultrasound (FUS), in combination with microbubbles (MBs), to deliver
SHIP-1 neutralizing therapies across the blood-brain barrier (BBB) to microglia to improve A phagocytosis and
restore neuronal health.
We propose two specific aims. In Aim 1, we will first develop a non-invasive, MR image-guided, FUS-
mediated, gene delivery strategy that yields efficient microglial transfection. To this end, we will interrogate
“acoustically activated” compositions of matter that involve (i) directly binding plasmid to cationic MBs, (ii) co-
injecting highly-PEGylated non-viral gene-bearing nanoparticles with MBs, and (iii) coupling gene-bearing
nanoparticles to MBs via thiol-maleimide interactions. FUS parameters to oscillate MBs, open the BBB, and
deliver transgene will be adjusted for each system to determine its capacity to transfect microglia. The best
performing system will be advanced to Aim 2, wherein we will inhibit the progression of Alzheimer’s-related
disease in mice by blocking microglial SHIP-1 via the delivery CRISPR-Cas9 plasmids for SHIP-1 deletion to
microglia in Alzheimer’s disease mice. We will test this therapeutic strategy in 5xFAD mice, as well as in models
of AD that develop progressive A amyloidosis (APPSAA mice), tauopathy alone (PS19 mice), and combined A
and tau pathology (APPSAA mice crossed with PS19 mice to generate APPSAA x PS19 mice). The potential for the
treatment to reduce A deposition, phospho-tau, neurofibrillary tangle, neuroinflammation, and CNS pathology,
and improve neural function, will be assessed. Morris water maze (MWM) and Y tests will be used to assess the
ability of the treatment to hinder cognitive decline in each of the AD mouse models. Ultimately, to our knowledge,
this will be the first ever attempt to implement FUS-directed gene delivery technology to selectively modulate
microglial responses and limit Alzheimer’s-related disease progression.

Public health relevance
Gain-of-function mutations in INPP5D, which encodes for the SH2-domain-containing inositol phosphatase SHIP-1, have recently been linked to an increased risk of developing late-onset Alzheimer’s disease. In our preliminary studies, we found that SHIP-1 deletion in brain-resident macrophages leads to greatly improved neuronal health as well as increased mobilization of microglia to amyloid beta plaques. The goal of this proposal is to also evaluate the therapeutic efficacy of targeting SHIP-1 with emerging focused ultrasound (FUS)-based gene therapy approaches to limit Alzheimer’s-related disease progression.